Comparative Medicine Center Upgrade

DESCRIPTION (provided by applicant): Salus University, formerly the Pennsylvania College of Optometry (PCO), was originally established as a single purpose educational institution graduating eye care professionals with the Doctor of Optometry (OD) degree. PCO then expanded its horizons within health professions education, by the addition of clinical training programs in rehabilitation and audiology and, most recently adding a physician's assistant's (PA) program. Salus University has a long-standing emphasis in biomedical research, and maintains a1648 sq. ft. vivarium plus a 492 sq. ft, quarantine area in support of its biomedical research program. The following proposal is for equipment that would accomplish two major goals of the institution. These goals are to improve the quality of the environmental control of the vivarium by purchasing and installing a new HVAC system to replace the current aging system and also assure the continuity of the environmental control of the vivarium by purchasing and installing a dedicated emergency power generator of sufficient capacity to operate the HVAC and other critical husbandry and program requirements.